Modulation of aging through mechanisms of nutrient demand and reward

Project Summary
Unrelenting growth in the number of elderly in our society and the resulting impact on the prevalence of
age-related disease will have dramatic economic and health-related consequences over the next two decades.
Although the causes and consequences of many diseases, including cancer and dementia, are slowly being
unraveled, the mechanisms that underlie advanced age as the most significant risk factor associated with these
disease states are relatively unknown. This is an important issue because single interventions that impact
mechanisms of aging would be expected to ameliorate or eliminate multiple pathologies and diseases. We are,
therefore, not just talking about extending lifespan; advances in understanding the basic biology of aging
would have tremendous general health benefits as well. Our understanding of mammalian aging has been
greatly stimulated over the past decade by research in simple model systems. Arguably, today’s most effective
aging-related interventions in mice target sirtuin genes, as well as TOR and insulin/IGF signaling pathways, all
of which were first identified in Saccharomyces cerevisiae, Caenorhabditis elegans, and Drosophila melanogaster.
In recent years, molecular neuroscience, often using simple model organisms like Drosophila, has provided
a well-defined framework for dissecting the causes and consequences of motivated behaviors. Homeostatic
drives are as influential in this process as are rewarding experiences, and the neurons and neural circuits that
influence motivation for foraging, mating, and many other behaviors also affect cellular pathways throughout
the body, even those thought to be largely cell-autonomous. We have evidence that the circuits and neural
states that encode feeding motivations are important modulators of aging. More specifically, our hypothesis is
that specific mechanisms that evaluate internal and external nutrient availability and initiate physiological
changes associated with states such as hunger and satiety play important roles in the modulation of behavior
and lifespan.
Harnessing the neurobiology of simple model systems to study the impact of how physiological decisions
are made in response to evaluated energy status will yield insights into the broad influence of nutrients on
longevity across taxa, including humans. It will also provide an understanding of the molecular details about
how neuronal inputs orchestrate cell-autonomous and non-autonomous mechanisms to insure survival and
health in a complex organism. The innovative nature of this proposal, which derives from the uniquely
appropriate tools available in Drosophila together with a novel perspective about the importance of evaluative
and motivational neural circuits on lifespan, provides the creativity and experimental power to develop and
test hypotheses about the cell non-autonomous control of aging that have not been previously considered. In
addition to providing an opportunity to discover basic mechanisms of aging, our work may also lead to
creative intervention strategies that ameliorate aging-related functional decline in humans.

Public health relevance
Project Narrative All organisms continuously perceive and evaluate nutrient availability, demand, and palatability. Recent research has shown that homeostatic drives are as influential in this process as are pleasurable experiences, and our work using the fruit fly, Drosophila melanogaster, has established that aging is modulated by these motivational states. Our proposed studies will dissect the molecular mechanisms through which neural states of feeding motivation influence aging and physiology in flies to illuminate how similar processes may control healthy aging in mammals.